100 Additional fresh samples for verification of assay to replace the original proposed banked samples that cannot be used due to repeated exposure to freezing and thawing.

James, Laura P
Project Summary/Abstract
The original plan for development of AcetaSTAT was to use banked samples of serum collected
from acetaminophen overdose patients to verify the effectiveness of the assay prior to verification
and validation efforts. However, during the development of the work it has become apparent that
banked samples cannot be used due to their instability and repeated exposure to freezing and re-
thawing of samples. The assay is intended for immediate use by the clinician, so although it
appears to be sensitive to sample age, this will not impact the final intended use. However, the
lack of more recent samples has delayed the project and we have determined it will be necessary
to collect fresh samples from patients with acetaminophen exposure.

Public health relevance
James, Laura P Project Narrative The original plan for development of AcetaSTAT was to use banked samples of serum collected from acetaminophen overdose patients to verify the effectiveness of the assay prior to verification and validation efforts. However, during the development of the work it has become apparent that banked samples cannot be used due to their instability and repeated exposure to freezing and re- thawing of samples. Approximately 100 fresh samples will be collected from 3 sites. A common IRB will be used to collect the samples that will then be shipped to our CLIA/CAP lab for analysis and then to our development partner DCN Diagnostics for use in completing the optimization of the assay prior to the Reproducibility analysis and Clinical Trial.